Administrative Core

The long term objectives of this Program Project are to elucidate host and viral mechanisms that tilt the interaction of herpes simplex virus (HSV) and neurons either towards lytic infection or towards latency. HSV latency is the most fascinating biological property ofthe virus and its most important clinical feature, and understanding HSV latency may lead to new therapies or even a cure for this widespread pathogen. The three projects that are central to the Program Project all assess the effects of viral and host mutants or certain treatments on viral gene expression and chromatin status during establishment, maintenance, and reactivation of latency, either in mice or in vitro. The assays used for these measurements require specialized equipment, training, attention to detail, and careful analysis to guarantee that they are truly quantitative. Thus, to ensure standardization and quality and to allow comparisons of results across all three projects, it is highly desirable to have these assays performed by a core. A specific aim of this core then is to isolate nucleic acids and perform standardized measurements of 1) viral DNA, which are normalized by measuring host DNA; 2) viral mRNAs, which are normalized by measuring a host mRNA; 3) viral miRNAs, which are normalized by measuring a host miRNA; and 4) occupancies by particular chromatin proteins on particular regions of viral DNA (chromatin immunoprecipitation, ChIP), which are normalized to occupancy on a host gene. These four assays use real-time polymerase chain reaction (PCR) based methods. An additional assay uses in situ hybridization to detect latency-associated transcripts in neurons. A second aim of the core is to train personnel from the projects in these assays should there be too large a volume for the core or should the personnel wish to develop new assays. A third aim is to maintain the equipment needed to conduct the assays.

Public health relevance
RELEVANCE (See instructions): The gene expression core performs important assays for the projects, and thus facilitates research to understand herpes simplex virus (HSV) latency, which is the most fascinating biological and most vexing clinical aspect of this virus. Understanding HSV latency might lead to new treatments or even cures for HSV infections, which are widespread and, in some cases, life-threatening.